Defining and targeting epigenetic plasticity-driven drug resistance and immune escape in melanoma

Project summary
Melanoma is a heterogeneous tumor, with a high degree of phenotypic plasticity that allows for rapid adaptation
to BRAF-MEK inhibitor therapy. Initial therapeutic responses are typically followed by a period of quiescence in
which signaling is rewired to evade therapy, followed by the emergence of a bona fide resistant state. Little is
known about how the initial persister cell state transitions to an irreversibly resistant state, the role of the immune
system in the emergence of these lineages, and whether this resistant state can be targeted. In preliminary
studies we identified the type I histone deacetylase HDAC8 as a master regulator of a lineage switch to a
resistance-associated melanoma cell state. Activation of HDAC8 alters the phenotype of melanoma cells with
loss of function of lineage identity genes such as MITF, increased activity of AP-1/TEAD transcription factors
and resistance to therapy. The resistant cell state persisted even after removal of targeted therapy, and was
associated with increased mutational load. HDAC8 overexpression also led to the reduced expression of
melanoma antigens, increased levels of the immune checkpoint proteins and reduced T cell infiltration. We
believe the stability of this state may be at least in part be epigenetic due to altered acetylation and function of
transcription factors, cofactors as well as altered function of the cohesin complex involved in chromatin looping,
and gene expression. We hypothesize that HDAC8 is a master regulator of a resistance-associated melanoma
cell state and represents a target for the prevention of lineage switching. In this proposal, we will use multi-omics
approaches (ATAC-Seq, scRNA-Seq, Hi-C, proteomics) to define the mechanisms by which HDAC8 reprograms
melanoma cells, and will determine if HDAC8 affects the cohesin complex, leading to fixed resistance-conferring
genetic or epigenetic changes. We will utilize a mouse model of BRAF/PTEN-HDAC8-driven melanoma and
single cell RNA-Seq to investigate how the HDAC8 modulates the immune microenvironment leading to the
emergence of drug resistant melanoma lineages. We will specifically determine whether HDAC8 drives a
transcriptional program associated with decreased MHC class I and antigen expression leading to decreased
tumor-T cell recognition. Further studies will define whether JUN-mediated transcription of IL-11 reprograms the
myeloid compartment leading to a suppressive melanoma immune environment that eradicates tumor-reactive
CD8 T cells. CRISPR screens will be performed to identify targets to prevent the emergence of drug resistant
lineages in mouse models. We will then evaluate these targets and HDAC8 inhibitors as strategies to improve
therapeutic responses to BRAF-MEK inhibitor and immune checkpoint inhibitor therapy in syngeneic mouse
melanoma models. We expect that new insights into the mechanisms underpinning the emergence and
maintenance of drug resistant lineages in melanoma will lead to the development of new therapeutic strategies
to improve the depth and duration of responses to immunotherapy and targeted therapy in melanoma. Our
findings will have important implications across multiple cancer types and many different therapies.

Public health relevance
Project narrative Treatment of melanoma with drugs leads to the emergence of new cell lineages that are drug resistant. In this proposal we will explore whether the new cell states that convey resistance in melanoma are dependent upon an epigenetic enzyme called histone deacetylase HDAC8. We will determine how activation of HDAC8 allows melanoma cells to survive in the presence of drug and to evade immune attack, and will develop new therapeutic strategies that limit HDAC8-mediated drug resistance.